RENAL STUDIES IN TYPE I GLYCOGEN STORAGE DISEASE

Studies are designed to elucidate the factors responsible for the glomeruler hyperfiltration seen in patients with GSD-I. The natural history of progressive renal damage is assessed by using both functional studies and quantitative morphometric analysis of renal biopsies.